Subcellular Plasticity Mechanisms of Hippocampal-Dependent Memory Formation and Consolidation

PROJECT SUMMARY/ABSTRACT
Episodic memories formed from a single experience can be used to guide behavior throughout the lifetime.
Memories are thought to be encoded during ‘online’ periods of awake exploration and subsequently consolidated
during sleep. In the mammalian brain, the initial formation and consolidation of episodic memories rely on the
CA1 region of the hippocampus. Pyramidal neurons in CA1 (CA1PNs) form spatially selective firing fields (place
fields, PFs), which serve as the cellular basis for memory encoding. Despite decades of research, subcellular
mechanisms underlying memory encoding (Aim 1, F99 phase) and consolidation (Aim 2, K00 phase) remain
poorly understood. CA1PNs receive excitatory synaptic inputs that interact through somatic action potentials
that backpropagate into the dendrites (bAPs) and dendritic plateau potentials (PPs) that initiate in distal
dendrites. Recent evidence suggests that PFs in CA1PNs are formed through behavioral timescale synaptic
plasticity (BTSP) by generating conjunctive PPs and bAPs. These plateau-burst (PP-bAP) events are robust
signals for synaptic plasticity (SP). While BTSP is emerging as a critical cellular mechanism driving PF formation,
a significant knowledge gap exists concerning whether and how bAPs and PPs differentially contribute to BTSP.
To address this major knowledge gap, in the F99 phase, I will test the hypothesis that synaptic plasticity requires
the interaction of bAPs and PPs during BTSP by measuring SP at single synapses after decoupling somatic and
dendritic activity using a combination of tools that allow electrophysiological manipulation of somatic membrane
potential and optogenetic manipulation of afferent inputs to distal dendrites in behaving mice. For my postdoctoral
work in the K00 phase, I will study the subcellular mechanisms responsible for refining and consolidating the
plasticity acquired during awake conditions into long-term memory during sleep. To study this, I will build on my
skills gained in the F99 phase, by combining intracellular recordings and dendritic imaging with extracellular
physiology and modeling to relate single-cell activity to different sleep states. Ultimately, I aim to provide a deeper
understanding of fundamental mechanisms controlling dendritic integration of synaptic activity and develop direct
experimental approaches linking sleep-specific dendritic activity to memory consolidation. These goals directly
align with the BRAIN Initiative objective of linking neural function and behavior by combining new
electrophysiological and imaging technologies to image single cells at high resolution across time. These
experiments will deepen our understanding of how physiological signals are produced and transmitted in
dendrites and will also help to identify key mechanisms behind neuronal diseases such as Alzheimer's and other
pathological memory-related disease states. The support of the DSPAN F99/K00 award will allow me to merge
techniques spanning multiple fields in neuroscience to further our understanding of memory formation and
consolidation, and ultimately provide me with the necessary training to achieve my long-term goal of becoming
an independent investigator.

Public health relevance
PROJECT NARRATIVE To understand the neurobiological basis of memory disorders, we need to first grasp how memories are encoded and consolidated under normal, healthy conditions. This proposal aims to combine new high-resolution optical, electrophysiological, and molecular approaches to characterize the cellular and subcellular mechanisms of memory formation and storage under physiological conditions. These experiments will deepen our understanding of the functional role of hippocampal dendrites in memory encoding and consolidation and will also help to identify key mechanisms behind neuronal diseases such as Alzheimer's and other memory-related disorders.